Alzheimer's Supplement: Vanderbilt Diabetes Research and Training Center

In response to NOT-AG-20-034 (Alzheimer's-focused administrative supplements for NIH grants that are not focused on Alzheimer's disease), the Vanderbilt Diabetes Research and Training Center (DRTC, P30; DK20593) proposes to expand their long-standing efforts to discover, apply, and translate scientific knowledge about diabetes, obesity, and metabolism to now include research at the intersection of Alzheimer's Disease and related dementias (ADRD) and diabetes. Specifically, we will establish a Pilot and Feasibility (P&F) program that will encourage and allow Vanderbilt investigators who are not currently working on ADRD to initiate ADRD-related research. We will be assisted by a strong collaboration with the Vanderbilt Memory and Alzheimer's Center (VMAC) that houses an interdisciplinary team of scientists and clinicians committed to discovering the root cause of Alzheimer's disease. We propose two aims: 1) Establish a Pilot and Feasibility (P&F) Program that fosters collaborative, interdisciplinary research on ADRD by diabetes-related investigators. By leveraging Vanderbilt's more than 25-year experience overseeing a NIDDK-supported diabetes-related P&F program, we will solicit P&F grant applications from Vanderbilt scientists who are not working on ADRD. P&F proposals will focus on ADRD-related research and encourage multidisciplinary collaborations with a focus on the connection of diabetes or obesity and ADRD. 2) Use P&F-funded investigators and grants to facilitate and enhance interactions other investigators in the DRTC and VMAC. To amplify the impact of the research supported by the P&F grants, we will invite the P&F grant awardees plus other investigators and scientists working in related areas to attend a Collaborative Research Symposium focused on the intersection of diabetes and ADRD. With the goal of facilitating interactions, building future collaborations, and sustaining the impact of P&F program, we will especially work to involve investigators and trainees. Through these efforts the Pilot and Feasibility (P&F) Program will promote research at the intersection of ADRD and diabetes or obesity.

Public health relevance
Narrative In response to NOT-AG-20-034 (Alzheimer's-focused administrative supplements for NIH grants that are not focused on Alzheimer's disease), the Vanderbilt Diabetes Research and Training Center (DRTC, P30; DK20593) proposes to expand their long-standing efforts to discover, apply, and translate scientific knowledge about diabetes, obesity, and metabolism to now include research at the intersection of Alzheimer's Disease and related dementias (ADRD) and diabetes. Specifically, we will establish a Pilot and Feasibility (P&F) program that will encourage and allow Vanderbilt investigators who are not currently working on ADRD to initiate ADRD-related research. We will be assisted by a strong collaboration with the Vanderbilt Memory and Alzheimer's Center that houses an interdisciplinary team of scientists and clinicians committed to discovering the root cause of Alzheimer's disease.